Mechanism of extracellular electron transfer in Gram-negative bacteria

Toxic contaminants, such as heavy metals and organic compounds, pose serious health threats to sur-
rounding communities. Bioremediation, which uses living organisms such as bacteria to degrade, detoxify, or
remove pollutants, has emerged as an environmentally sustainable approach to cleaning up polluted sites. The
Gram-negative bacterium Shewanella is capable of reducing metals like uranium and chromium to less-toxic
forms as well as of degrading organic compounds through redox reaction as part of their anaerobic respiration.
Leveraging the anaerobic respiration mechanism in Shewanella can thus revolutionize bioremediation and
wastewater treatment technologies. The biological foundation of this anaerobic respiration is the extracellular
electron transfer (EET) process, in which the bacterium exchanges electrons with extracellular electron accep-
tors or donors by employing a cascade of proteins residing at different cellular compartments, in which CymA,
an inner-membrane-anchored protein, acts as a central hub of EET pathways for relaying electrons across the
inner-membrane, either toward outside the cell or into the cell. Little is known, however, on how the involved
proteins, especially those at different cellular compartments, coordinate spatially and temporally in the cell to
ensure efficient electron transfer. The long-term goal here is to understand how electroactive bacteria carry out
EET to provide knowledge to better utilize or engineer such bacteria for bioremediation of contaminated sites.
The objective here is to define how CymA coordinates spatially and temporally with its redox partners to mediate
efficient EET across the cell envelope in live Shewanella oneidensis cells. Preliminary studies reveal that CymA
changes its spatial distribution in the cell from a dispersed pattern into a punctate pattern when actively engaged
in EET, which leads to our hypothesis that CymA and its redox partners dynamically cluster and colocalize spa-
tiotemporally in the cell to ensure efficient electron transfer across the cell envelope. The research will test this
hypothesis and use quantitative single-molecule/single-cell imaging approaches, together with specific protein
tagging, genetic manipulations, single-cell (photo)electrochemical manipulation/measurements, and bulk bio-
chemical assays. There are two aims: 1) Define the spatial pattern and temporal dynamics of CymA in the cell
in relation to cell's EET activity. 2) Define the spatiotemporal pattern of periplasmic EET partners and their colo-
calization with CymA in the cell. The research is significant because it will provide insights into the mechanism
of EET across the cell envelope of Gram-negative bacteria and the molecular basis of anaerobic respiration in
electroactive bacteria, and it will provide knowledge to potentially engineer S. oneidensis and other electroactive
bacteria for bioremediation applications. The research is innovative because of the novel mechanism of spatio-
temporal colocalization of EET proteins, as well as of the innovative combination of single-cell/molecule fluores-
cence microscopy, electrochemical manipulation, and photoelectrochemical microscopy.

Public health relevance
The proposed research is relevant to public health by generating fundamental knowledge of bacterial extracellular electron transfer that underlines these bacteria's ability in detoxifying heavy metals and toxic organics. This knowledge can help improve bioremediation and wastewater treatment technologies toward removing health threats to surrounding communities. Thus, the proposed research is relevant to the part of NIGMS's mission that pertains to laying the foundation for disease prevention.